Mast Cell Activation as a Common Mechanism of Pulmonary Toxicity by Chemical Threat Agents

Project Abstract
The Department of Homeland Security considers numerous chemical threat agents a concern for human health,
specifically those that are acute pulmonary toxicants. In acute lung injury, inflammation is critical thus we propose
that inflammation is a common mechanism of lung injury caused by chemical threat agents due to mast cell
activation. We and others have shown mast cell activation to be critical in response to a wide range of xenobiotics
including nitrogen mustard, ozone, diesel exhaust, insecticides/herbicides, cigarette smoke, heavy metals and
nanoparticles as examples. Mast cells are a logical cell type to study in pulmonary injury from chemical threat
agents due to 1) their location at interfaces with the external environment (e.g., lung); 2) their roles as sensors
for initiating both innate and adaptive immune responses; and 3) their immediate response to danger signals
through degranulation and release of preformed mediators. We have demonstrated that mast cell activation is
a major contributor to the pulmonary toxicity and inflammation observed following nitrogen mustard (NM),
chloropicrin and formaldehyde exposure. Currently there are few shared mechanisms which have been identified
between these chemical threat agents, thus identification of common pathways would be beneficial for future
therapeutic targets and biomarkers of exposure. Here, we propose two specific aims to provide confirmatory
data on the role of mast cells in pulmonary injury resulting from exposure to chloropicrin (fumigant/pesticide) and
formaldehyde (industrial chemical). Our overall hypothesis is that activation of mast cells is a common
initiating step in recruitment and propagation of immune responses in the lung across several classes
of chemical threat agents. In aim 1, we will Confirm the in vivo contribution of mast cells to pulmonary injury
and inflammation resulting from chemical threat agents in Cpa3-Cre mast cell deficient mice. In aim 2 we will
Determine role of mast cells in lung injury using a novel human lung-on-a-chip model where we have
incorporated mast cells. Collectively, our goal is to establish activation of mast cells as a common mechanism
across several chemical classes which are linked with pulmonary toxicity. Confirmation of these findings will
allow identification and development of novel therapeutic targets for prevention and/or treatment of the effects
of these potential chemical warfare agents through targeting of mast cells.

Public health relevance
Chemical threat agents are a concern for public safety worldwide, yet we understand little about the mechanisms responsible for acute lung injury. Our recent research has demonstrated that nitrogen mustard, chloropicrin and formaldehyde elicit acute lung toxicity through mast cell activation. In the proposed studies, we will confirm a role for mast cells in lung injury using an additional mast cell deficient mouse model and a novel human lung on a chip in which we have incorporated mast cells. The goal will be to further confirm the role of mast cells in chemical threat agent lung toxicity to allow future therapeutic development targeting this critical cell type.